Development of a single-use, ready-to-use, sterile, dual chamber, dual syringe sprayable hydrogel to prevent postsurgical cardiac adhesions.

PROJECT SUMMARY/ABSTRACT
There are over 900,000 cardiac surgeries per year in the US, of which, over 20% are reoperations. While
surgeries have become safer, over 70% of these reoperation patients will have severe adhesions present that
fuse the heart to other tissues in the chest cavity. Cardiac adhesions impair cardiac function and inhibit surgical
access in reoperation procedures, leading to increased mortality, morbidity, surgery complexity, operating times,
and hospital costs. While a variety of different materials have been investigated in animals and humans, no
materials, to date, have been capable of preventing adhesion formation post-cardiac surgery. The main
approaches for attempting to reduce cardiac adhesions include drugs, physical barriers, and polymer solutions.
Drugs disrupt beneficial biochemical pathways vital for wound healing and do not achieve adequate drug
concentration at the site of action. Barriers have shown limited clinical efficacy due to degradation issues and
requiring sutures. Polymer solutions require excessively large volumes, possess high swelling (leading to cardiac
tamponade), short lifespans, and/or dislodge from the heart. Considering these limitations, TissueShield was
engineered and developed in collaboration with cardiac surgeons. We propose to develop and clinically translate
TissueShield, a novel single-use, ready-to-use, sterile, dual chamber, dual syringe sprayable hydrogel to prevent
postsurgical cardiac adhesions. TissueShield is composed of a rapidly forming poly(ethylene glycol) (PEG)
hydrogel that is cross-linked by oxime bonds and includes a tissue binding moiety to ensure the product remains
adhered to the heart. Our approach is a 3-component polymer system that can be easily sprayed directly onto
the heart forming a robust anti-adhesion layer within seconds. This system has already been optimized to control
the degree of swelling and degradation time to prevent adhesions and to not interfere with cardiac function in rat
cardiac adhesions models and an initial small pilot study in a porcine model. No product has been shown to have
our features (tissue binder, low swelling, and lifespan). Herein, the objective is to prepare TissueShield for clinical
trials by establishing preclinical safety, transitioning to and testing a commercially viable two chamber system,
completing product development, and scaling up and transferring manufacturing. TissueShield will be the first
commercially available sprayable anti-adhesions product designed specifically for preventing cardiac adhesions.

Public health relevance
PROJECT NARRATIVE Cardiac adhesions impair heart function and inhibit surgical access in reoperations, leading to more complicated and longer surgeries, increased hospital costs, and worse patient outcomes. Currently, there are no approved and available products to prevent postsurgical cardiac adhesions, and hence no standard of care for prevention. TissueShield was specifically designed for the heart to prevent postsurgical cardiac adhesions, and we propose to prepare TissueShield for clinical trials by establishing its safety, finishing its product design, and scaling its manufacturing process.